Enhancing CBTN digital pathology processing pipeline through the use AWS cloud-based services to enable automation, parallel processing, and rapid use of AI/ML analytics

PROJECT SUMMARY
The Gabriella Miller Kids First pediatric research program is a collaborative initiative with the goal of
understanding the etiology and drivers of pediatric diseases. Related efforts include (1) developing data-driven
platforms, workflows and tools; (2) accelerating discovery of generic causes and shared biologic pathways
within and across conditions; and (3) enabling rapid translation of scientific discoveries to personalized
treatments. Through this program, some of the largest, multi-modal pediatric datasets have been generated,
harmonized, and released for use by the research community. In parallel, developed software platforms have
enabled streamlined, user-friendly workflows in cloud environments to empower data exploration to analysis.
While this work has significantly advanced the use of integrated datasets, particularly for genomics and clinical
data, related advancements for medical imaging data have been slower. In the present project, we focus on
digital pathology data in research contexts and aim to enable the use of modern cloud infrastructure and
processes for Kids First digital pathology slides. Specifically, we will explore, implement, optimize, and assess
cloud platforms and services to reduce current challenges in data ingest and release, and preparation of digital
slide images for downstream analytics. The selected cloud solutions are expected to enable workflow
automation, scaling of computing resources, and full support of the entire data lifecycle. This should drastically
reduce the operational and computational costs of utilizing Kids First digital pathology data across research
contexts. Together, this project will bridge digital pathology data and tools with high-performance cloud
workspaces to accelerate their use with advanced analytics and multi-modal integration for all Kids First
pediatric data.

Public health relevance
PROJECT NARRATIVE Digital pathology data has the potential to provide novel, rich characterizations of pediatric diseases; however, collecting and utilizing digital slide images in research contexts is met with significant operational and technical challenges. In this project we implement and test cloud platforms and services for the large-scale intake and preparation of digital slides under the Gabriella Miller Kids First pediatric research program. Through this work we focus on automation, flexibility, and scalability, and aim to bridge digital pathology data and requisite software tools with high-performance cloud workspaces to accelerate their use with advanced analytics.